CHOP Institutional Training in Pediatric Research

Abstract
This application seeks to renew an NICHD-sponsored National Research Service Award T32 that supports
fellowship training in the Department of Pediatrics at the Children's Hospital of Philadelphia (CHOP) and the
Perelman School of Medicine at the University of Pennsylvania (Penn). A continuous commitment to pediatric
research is necessary to ensure advances in the health of children, adolescents, and young adults. Establishing
and maintaining a nurturing environment for pediatric subspecialty trainees to evolve into independent scientists
is the foundation of our institution’s commitment to making advances in pediatric research. The long-term
objective of our NRSA-T32 program is to provide an environment that promotes the maturation of pediatric
subspecialty trainees into rigorous independent investigators who are addressing important questions relevant
to the health and well-being of the pediatric population. The program leverages the robust research and training
resources at CHOP and Penn, including a core of accomplished faculty mentors in the Department of Pediatrics
and other departments at CHOP who are performing rigorous science in areas germane to pediatrics, have a
strong record of successful mentoring and collaboration, and have a strong record of extramural funding. Four
trainees will be supported each year and will be drawn from subspecialty fellows in the Department of Pediatrics,
with particular emphasis on recruitment of women, underrepresented in medicine minorities, individuals with
disabilities, and other disadvantaged individuals. Trainees will typically receive support for two years of
investigation and will emphasize the application of basic and translational science techniques, rigorous clinical
and epidemiologic methods, novel approaches to community science, and application of contemporary methods
for health equity research. Collectively, these approaches will serve to improve our understanding of pediatric
diseases and to develop new and effective preventative and therapeutic interventions that optimize the health of
children. Trainees will have access to the full array of research centers and cores at CHOP and Penn and will
also benefit from extensive educational activities at CHOP and Penn, including a robust infrastructure for
responsible conduct of research, master degree programs, certificate programs, and a range of seminars, among
other research related resources. The Principal Investigator/Program Director, Training Director, and Associate
Training Director will receive assistance from an advisory committee that includes internal research leaders,
external research leaders, and diversity recruitment officers and that plays a key role in selecting trainees,
monitoring the scholarly progress of trainees, and ensuring optimal operation of the program. The renewal of
this T32 program will continue the tradition established during the past 22 years, capitalizing on the tremendous
strengths of CHOP and Penn, with outstanding subspecialty fellows, accomplished mentors, and numerous
cutting edge research programs.

Public health relevance
Project Narrative The health of children, adolescents, and young adults is paramount to the health of society and requires a continuous, comprehensive, and collaborative research focus from established physician scientists across a range of pediatric subspecialties. This Children’s Hospital of Philadelphia NRSA-T32 training program provides a robust environment for a diverse group of pediatric subspecialty trainees to develop into future independent physician-scientists, pursuing rigorous basic science, translational, clinical, community-based, and/or health equity research.